Electrical Activity Patterns in Onset and Cessation of Atrial Fibrillation

PROJECT SUMMARY/ABSTRACT
This project aims at developing, validating and using novel mapping approaches to enhance the understanding
of excitation dynamics in early atrial fibrillation (AF) to potentially improve its treatment. AF is a progressive
arrhythmia afflicting more than 2.5 million Americans and 33 million worldwide; it increases risks for morbidity
and mortality and is the leading cause of embolic stroke. For patients with AF, anti-arrhythmic drugs perform
poorly and ablation, with controversial success rate and long-term effects, is often the only therapy available. It
is generally accepted AF initiates as short paroxysmal episodes that get prolonged, more complex and more
challenging for therapy with time. Thus, advancing our understanding of the mechanisms of the arrhythmia and
how to device better therapies for it at its very early stage are of paramount importance. It is also accepted that
the alterations promoting the onset and regulating the maintenance of fibrillation have significant regional as well
as inter-patient heterogeneity requiring extensive mapping. It is therefore the general objective of this proposal
to develop novel mapping approaches to improve characterization of mechanisms underlying the link between
atria-wide patterns of electrical activation initiating AF and the heterogeneous atrial substrate. The proposed
project will utilize detailed computer simulations and novel panoramic intracardiac optical mapping in isolated
sheep hearts, together with our new developments in singular value decomposition and reconstruction (SVDR)
of hierarchical energy modes, to test the general hypothesis that onset and cessation of highly dynamic patterns
of electrical activity during early AF can be predicted by the substrate heterogeneity and by local energy analysis
of the activity. Our specific aims are: (1) To demonstrate in computational models of the atria the mechanistic
links between transient activation patterns during early AF and the stationary energetic properties of the
substrate and activity. (2) To utilize a novel panoramic optical mapping and SVDR algorithms to demonstrate
the characteristics of dynamical activation patterns during initiation and early stabilization of sympathetic, vagal,
and stretched induced AF in the sheep isolated heart. (3) To demonstrate that SVDR and energy domain
parametrization of AF can localize targets for interventions to render the AF in the isolated sheep hearts non-
inducible. Accordingly, regions with maximal energy will be localized in the real-time across the entire atria and
their role in sustaining the AF will be tested by local and reversible cryo-ablation applications. Accomplishing our
aims will enhance understanding of early AF and provide solid new framework for mapping AF dynamics in
patients to potentially improve its therapy.

Public health relevance
PROJECT NARRATIVE Atrial fibrillation (AF) is afflicting over 33 million people worldwide to date and its prevalence is expected to increase dramatically in the future. This proposal aims at studying new modalities for characterizing the AF in computer and sheep models to describe new mechanisms of patterns of the electrical activity during its onset and cessation. Accomplishment of the proposal aims will enhance our understanding of AF and possibly lead to improved risk stratification and guide therapeutic interventions.